DIscovering SubPhenotypes and ENdotypes in pediatric SEpsis-induced MODS: the DISPENSE Study

Project Summary/Abstract
Sepsis is a “syndromic” definition reflecting patients with great heterogeneity in age, comorbidities,
pathophysiology, and inciting triggers. This heterogeneity likely contributes to a myriad of negative randomized
controlled trials (RCTs). The identification of higher-risk subgroups (e.g., subphenotypes) within these
heterogeneous disease states is a critical gap in knowledge prohibiting development of tailored treatments
targeting subgroups with similar biology (e.g., endotypes). Despite years of research, aside from timely
antibiotic administration, pharmacologic treatment has proven ineffective in decreasing mortality and morbidity
in children with sepsis associated multi-organ dysfunction syndrome (MODS) likely due, in part, to
heterogeneity in these patients. There is limited to no understanding of the progression of pathophysiologic
changes across the time course of pediatric severe sepsis, nor how those changes may be impacted by
tailored treatments. Clinical and/or plasma biomarker-based variables have been successfully used to identify
subphenotypes, while gene expression techniques have aided in identifying more mechanistically based
endotypes. The PRECISE GRACE2 (NCT05266001) and TRIPS (NCT05267821) trials offer an unprecedented
opportunity to identify subphenotypes in children with severe sepsis-induced MODS using latent class analysis
(LCA) and to gain insight into mechanistic differences between both LCA-defined subphenotypes and
PRECISE-defined subphenotypes over time and in response to treatment. Specific Aims are: 1. To test the
hypotheses that a) in children with sepsis-induced MODS, de novo LCA will identify subphenotypes, and that
b) clinical outcomes and c) response to treatment will vary between these subphenotypes. 2. To test the
hypotheses that genome-wide expression profiling will identify a) de novo transcriptomic subphenotypes that
will differ in outcome and response to treatment and that b) gene expression will identify treatment-triggered
molecular changes in either the transcriptomic, and/or LCA-, and/or PRECISE-defined subphenotypes.
Consistent with NICHD Pediatric Trauma and Critical Illness Branch research priorities, completion of this work
will confirm whether subphenotypes in children with sepsis-induced MODS exist and reflect underlying
mechanistic differences, thus allowing stratification into groups with differing risk (prognostic enrichment)
and/or potential responsiveness to targeted therapies (predictive enrichment) allowing identification of potential
treatable traits and new precision-based diagnostic and therapeutic targets in these highest-risk children.

Public health relevance
Narrative Sepsis associated with multiple organ system dysfunction syndrome (MODS) is associated with high morbidity and mortality in children. Aside from antibiotic administration, pharmacologic treatment has proven ineffective in both sepsis and sepsis-associated pediatric acute respiratory distress syndrome (PARDS), due in part to heterogeneity within patients with this syndrome. This proposal will provide proof of concept that children with sepsis-associated MODS can be stratified into subphenotypes/endotypes and will evaluate whether these subphenotypes/endotypes transition over time and in response to treatment, which will have a major impact on future treatment trial design and potentially decrease sepsis-associated morbidity and mortality.